Immunotherapy targeting the CD47-SIRPα axis to promote immune clearance of chronic infection

? DESCRIPTION (provided by applicant): The Weissman lab has discovered that cancer cells evade clearance by the immune system through increased expression of CD47, a surface molecule that binds to the inhibitory receptor called signal-regulatory protein alpha (SIRPα) on phagocytic cells, thereby inhibiting phagocytosis. I have found that persistently infected cells in a variety of infectious diseases also upregulate CD47 expression. Furthermore, I discovered that T cells upregulate SIRPα in response to prolonged activation, and together with collaborators have confirmed this in two distinct chronic viral infections. Most strikingly, T cell that upregulate SIRPα also have high expression levels of programmed cell death 1 (PD-1), a mediator of exhaustion. I hypothesize that the CD47-SIRPα axis is an immunomodulatory axis, whereby overexpression of CD47 in infected cells triggers SIRPα mediated blockade of both innate and adaptive immune clearance. This makes the CD47- SIRPα interaction an important target for novel immunotherapies. To this end we have developed multiple reagents to block this interaction, which we will test in vivo in mouse models of chronic infection as well as with human in vitro and patient ex vivo models. I will expand my exploration of SIRPα as a novel marker of T cell exhaustion to determine whether SIRPα is upregulated on exhausted human T cells from HIV infected individuals. I will also investigate the function of SIRPα on T cells. Concurrently w will test whether therapeutic blockade of SIRPα signaling, either alone or in combination with additional inhibitors of T cell exhaustion, can restore functionality of exhausted T cells or lead o clearance of the persistent infection. If successful the proposed experiments will demonstrate the preclinical efficacy of CD47 blockade in infectious diseases, identify a novel marker of T cell exhaustion, and specifically test if targeting the CD47- SIRPα axis can restore functionality to exhausted T cells.

Public health relevance
PUBLIC HEALTH RELEVANCE: It is critical that immune responses are tightly regulated to avoid extensive damage to the host. I have discovered the expression of the inhibitory receptor, SIRPa on dysfunctional "exhausted" immune cells during chronic infection. I will investigate if this protein is preventing the proper functionality of these cells, and whether blocking this proten can restore their ability to kill infected cells.